Granzyme B Genotypes in Scleroderma

Systemic autoimmune disease are a heterogenous and complex group of disorders of unknown etiology, characterized by the production of high titer autoantibodies directed against a variety of self-antigens. In many cases, specific autoantibodies are associated with unique phenotypes. Recent studies have demonstrated that the majority of autoantigens targeted across the spectrum of autoimmune diseases are cleaved efficiently by granzyme B (GrB) during cytotoxic lymphocyte granule-induced cell death, generating unqiue forms of these molecules not observed during other forms of apoptosis. Taken together with the numerous observations that cytotoxic lymphocytes are active in several autoimmune phenotypes, including scleroderma, lupus, polymyositis, and Sjogren's syndrome, these findings suggest that GrB may play a role in the generation and propagation of rheumatic diseases. It remains unknown whether differences in the expression and/or function of GrB influence the development or expression of any autoimmune disease. In this pilot proposal, we will address this question in a population of well-characterized and phenotypieally diverse scleroderma patients from the Johns Hopkins Scleroderma Center and controls matched for age, sex, and ethnicity from genetic studies ongoing at our institution. Scleroderma patients will include those with either the limited or diffuse form of the disease. These patients have been followed longitudinally and phenotyped thoroughly with respect to the presence or absence of overt (?) vascular disease, ischemic digital loss, interstitial lung disease, renal crisis, and pulmonary hypertension. DMA samples on these patients have been saved in the Bioassay Core. In order to define SNP haplotypes in Aim 1, we will sequence the entire GrB gene in 25 patients and 25 controls, including 1000 bp from the 5'and 3' UTRs. We will then perform SNP genotyping on 200 scleroderma and 200 control subjects, to define the allelic frequencies for GrB. In Aim 2, we will test for association between SNPs in the GrB gene and distinct clinical phenotypes and/or serological subsets of scleroderma.